Co-engineering Synthetically Programmed Cells and Biomaterials for Regenerative Medicine

Project Summary
The field of regenerative medicine focuses on addressing degenerative cell behaviors arising from issues like
aging, injury, autoimmune diseases, and cancer. Two main elements in regenerative medicine are cell therapies
and biomaterial scaffolds. Cell therapies have become an increasingly viable therapeutic strategy as ways to
control cellular behaviors have become ever more sophisticated. However, many current technologies to
engineer cellular behaviors rely on bulk delivery of soluble factors, which can lead to off-target effects on
surrounding tissues. Designer biomaterials provide physicochemical cues that govern migration, proliferation,
and differentiation of immune and stem cells encapsulated or in proximity to these surrogate extracellular
matrices. However, the influence of biomaterials over cell behaviors is limited, as many designs rely on activation
of native signaling pathways with responses that can be difficult to precisely engineer. Therefore, the overall goal
of this proposal is to develop a hydrogel biomaterial formulation that can control cellular behaviors in a user-
defined manner for regenerative medicine purposes. This hydrogel will interface with engineered cells to enable
artificial signaling in response to bioinert ligands that activate synthetic receptors. To achieve our goal, we will
use these methods: (1) Cells will be engineered with synthetic signaling receptors to allow for user-defined inputs
and outputs; (2) Hydrogel formulations will be designed to capture soluble ligands for dynamic activation of
engineered cells. We propose to accomplish this through three Specific Aims: (1) We will engineer a hydrogel
formulation that supports cell viability and is able to capture soluble bioinert ligands for tunable and inducible
reporter activation of engineered cells; (2) We will utilize this hydrogel formulation and engineered cells to
attenuate inflammation in a separate population of fibroblasts through production of cytokine antagonists; (3) We
will differentiate a population of multipotent cells encapsulated in our hydrogel formulation into osteogenic and
chondrogenic lineages. We hypothesize that this new hydrogel platform will allow for dynamic and user-defined
activation of encapsulated engineered cells in a spatially constrained and ligand-inducible manner. This research
will contribute a new technology for controlling cell behaviors for therapeutic functions that can be applied to a
range of disease states, such as insulin secretion for diabetes, growth factor secretion for wound healing, and
differentiation into muscle fibers for tissue regeneration. Here we also propose a multidisciplinary mentoring and
training plan in the areas of materials engineering, cell therapy, and synthetic biology that will provide high-level
training for the applicant in preparation for a career in cell therapies.

Public health relevance
Project Narrative We propose the development of a 3D hydrogel platform that can anchor soluble bioinert ligands, like GFP, for the activation of regenerative cell behaviors from cells engineered with synthetic Notch receptors. We hypothesize that this innovative technology will lead to tunable and dynamic control of cellular behaviors with high levels of spatial control from the captured ligands. To demonstrate the therapeutic potential of our platform, we will test inflammation attenuation and differentiation of multipotent cells to osteogenic and chondrogenic fates for musculoskeletal repair.